Systems analysis of immune responses to Norovirus infection in a human challenge model.

PROJECT SUMMARY/ABSTRACT
Noroviruses are a group of highly infectious viruses responsible for over 600 million cases of gastroenteritis
worldwide annually. Despite their widespread prevalence, currently there is no licensed vaccine against
norovirus infection and disease. Very little is known about the nature of innate immune responses to norovirus
infection in humans. In recent decades, advances in high-throughput “omics” technologies, along with the
computational algorithms developed to analyze and interpret such data, have created the ability to profile
immune responses at unprecedented depth and to better understand the complex interactions between the
numerous components of the immune system. Here we propose to delineate the transcriptomic responses in
human peripheral blood and stool collected from volunteers early after controlled infection with varying doses of
two different strains of Norovirus and to use them as early innate transcriptional predictors of the effective
adaptive anti-norovirus humoral and cellular immunity that develops later. We will perform transcriptomic,
cytokine, and innate (NK and CD14+) cell profiling of peripheral blood and transcriptomic profiling of stool
collected as part of two parallel DMID trials of healthy adults challenged with different strains and doses of
Norovirus (clinicaltrials.gov ID NCT02473224, GII.2 strain, n=38, and NCT04174560 GII.4 strain, n=45).
Samples will be collected pre challenge and on days 1, 3, 5, and 14 post-challenge, enabling profiling of the
response kinetics during the acute phase of infection. Integration of transcriptomic data with our recently
published atlas of human transcriptional responses across 13 vaccines, including many live attenuated vaccines,
will enable a comparative analysis that will provide deep insight into how immune responses to gastrointestinal
viruses, like Norovirus, may differ from those against respiratory or other types of viruses. Additionally, we will
utilize norovirus-specific antibody titer (IgA, IgG, and blocking antibodies) and antibody-secreting cell and
memory B cell frequency data, together with measurements of activated and cytokine (IFN-g, TNF-a, IL-2, IL-13
etc.) secreting Norovirus-specific T cells and combined single cell RNA and immune repertoire sequencing to
comprehensively evaluate the humoral and cellular immune responses to Norovirus infection. We will incorporate
the transcriptomic response data with machine learning approaches to identify transcriptional signatures of
innate immune activity that predict each parameter of anti-norovirus humoral and cellular immunity, leveraging
the independent trials as discovery/validation datasets to identify robust predictors. Together, these analyses
will provide deeper insight into the immune responses to wild-type norovirus infection in humans and help
understand mechanisms leading to the induction of effective anti-norovirus immunity. This information will lay
important groundwork and provide a unique reference to compare immune responses to potential Norovirus
vaccine candidates.

Public health relevance
PROJECT NARRATIVE Noroviruses are a group of highly infectious viruses responsible for over 600 million cases of gastroenteritis worldwide annually, for which there is no currently licensed vaccine. Using samples collected in a Norovirus human challenge model, this project seeks to profile innate immune responses to Norovirus infection and to identify important pathways for development of effective adaptive immunity. The resulting findings will help guide development of efficacious Norovirus vaccines.